Telomere loss and T cell aging in HBV vaccine response in HCV-infected individual

The overall goal of this proposal is to elucidate the mechanisms by which chronic viral infection mediates telomere
loss and T cell aging that may lead to vaccine failure, with an aim to develop effective means to improve vaccine
efficacy in virally infected individuals. To this end, we will use a model of hepatitis B virus (HBV) vaccine responses
in the setting of hepatitis C virus (HCV) infection. Due to shared risk factors and the prevalence of hepatitis B and
hepatitis C (200~300 million people are infected with each of the virus worldwide; the two hepatic viral infections are
unequally distributed but more concentrated in some regions than others, increasing the chance of dual infection),
co-infection of HBV with HCV is common and is associated with an increased morbidity and mortality; as such, HBV
vaccination is required to prevent HBV super-infection in HCV-infected individuals. However, HBV vaccine
responses in this setting are often blunted, with only ~50% seroconversion (Anti-HBs > 10 IU/ml) compared to >90%
in age-matched healthy subjects (HS). This poor vaccine response is also observed in HIV-infected subjects and in
other immunocompromised hosts, including the elderly. Attempts to improve immunization responses in both
infected and aged humans have been unsuccessful, in part due to our poor understanding of the mechanisms that
can dampen vaccine responses in these settings. Recently, we and others have found that chronic viral (HIV, HCV)
infection is often associated with T cell exhaustion and senescence, as demonstrated by overexpression of
exhaustion and aging markers (such as PD-1, Tim-3, KLRG-1, and DUSP-6), and, in particular, accelerated erosion
of telomeres - suggesting excessive proliferative pressure or telomeric DNA damage. Telomere integrity is a key
feature of linear chromosomes that preserves genome stability and function, whereas telomere erosion is a hallmark
of cell aging or senescence that leads to cell dysfunction or apoptosis, therefore telomere repair is essential to life.
While the telomere length is maintained in most cases by a telomerase that prolongs telomeric sequences, we found
that telomerase activity is intact, whereas ataxia-telangiectasia-mutated (ATM) - a DNA damage repair enzyme - is
inhibited, in naïve CD4 T cells derived from HCV-infected subjects. How telomeric DNA damage and repair signaling
pathways are dysregulated in the context of HBV vaccine response during HCV infection remain largely unknown.
In this proposal, we hypothesize that i) telomere loss-mediated T cell aging plays a pivotal role in HBV vaccine failure
in HCV-infected individuals; and ii) lack of ATM-dependent telomeric DNA repair accelerates T cell aging and HBV
vaccine failure in HCV infection, thus restoring this telomere repair machinery will open new avenues to protect T
cells from aging and to maintain immune competency. To test this hypothesis, we will: 1) characterize the role of
telomere loss and T cell aging in HBV vaccine failure during HCV infection; 2) define the mechanisms and impact of
ATM deficiency on T cell dysregulation during HCV infection. This translational study is significant in that it will
provide a working model to explore mechanisms that may be fundamental to diminishing immune (vaccine)
responses that are observed in many chronic infectious diseases, including but not limited to HCV. Understanding
such mechanisms is critical for developing approaches to improve vaccine efficacy in the setting of
immunocompromised conditions, it is thus significant, timely, and relevant to the Veterans as well as public health.

Public health relevance
As is observed in the elderly, individuals with HCV infection often do not respond well to HBV vaccinations, and overall efforts to boost vaccine responses in HCV-infected individuals are generally futile - in part due to our poor understanding of the underlying mechanisms that can blunt vaccine responses. We and others have shown that chronic viral (HCV, HIV) infection can accelerate premature T cell aging, with telomere loss as a hallmark of cell senescence, although the mechanisms underlying this process remain largely unknown. In this proposal, we will investigate the role and mechanisms of telomere loss and T cell aging in HBV vaccine failure emanating from HCV infection. This study will facilitate our understanding of the fundamental mechanisms underlying immune aging in chronic viral infection and develop effective means to restore immune competency in HCV-infected subjects. It may also shed light on the shared mechanisms and approaches to improve vaccine efficacy seen in other immunocompromised conditions; it is thus both significant and timely.